Katies for Aging Research and Equity (KARE) at St. Catherine University

The Katies for Aging Research and Equity (KARE) program at St. Catherine University is
an innovative and integrated research education program that will advance diversity in aging
research through a seamless blend of student support, education, and mentored research
opportunities. To prepare the next generation of underrepresented minority women to be
leaders in aging research, the KARE program will address the following specific aims: (1)
develop and implement a supportive infrastructure for KARE scholars from the time of
recruitment to beyond graduation, (2) launch a Gerontology minor for KARE scholars to become
engaged and integrated in the study of health disparities in aging, and (3) cultivate authentic
research in aging through mentored research opportunities. From the time of recruitment into
the KARE program, scholars will receive holistic support through community building activities,
career development programming, academic and research mentorship, and networking events
within the larger aging research community. Scholars will also remain connected to the program
beyond graduation as part of an active community of KARE alumnae. In addition, scholars will
receive a cross-disciplinary education in Gerontology with a focus on age-related health
disparities and interprofessional collaboration. In alignment with the NIA’s Health Disparities
Research Framework, KARE scholars will complete coursework that focuses on the
environmental, sociocultural, behavioral, and biological factors that underlie age-related health
disparities among diverse populations of older adults. Importantly, each KARE scholar will be
engaged in mentored aging-related research through multiple on-campus and off-campus
research opportunities. As a complement to ongoing aging research at St. Catherine University,
external partnerships have been developed with the Mayo Clinic Kogod Center on Aging in
Rochester, MN and the HealthPartners Neuroscience Center in St. Paul, MN. KARE scholars
will have the opportunity to focus on clinical, behavioral, or biomedical projects within the field of
aging research either at the University or with one of the KARE partner institutions. Through the
synergy of support, education, and research, the KARE program will comprehensively train
scholars for successful research careers in aging.

Public health relevance
Project Narrative The Katies for Aging Research and Equity (KARE) program at St. Catherine University will train the next generation of underrepresented minority women for successful aging research careers. The KARE program will advance diversity in aging research and support authentic biomedical, behavioral, and clinical research in aging-related disciplines. In alignment with the NIA’s Health Disparities Research Framework, the KARE program shares the ultimate goal of reducing health disparities among older adults from diverse ethnic and cultural backgrounds.